Emory Specialized Center of Research Excellence (SCORE) on Sex Differences

PROJECT SUMMARY/ABSTRACT: Biostatistics and Bioinformatics Resource Core (BBRC)
During the inaugural funding cycle of Emory University’s U54 NIH/ORWH-funded Specialized Center of
Research Excellence on Sex Differences (Emory SCORE), the overall objective of the Biostatistics Resource
Core (BRC) was to enhance the success of the Emory SCORE research program. We accomplished this
through high quality collaborative support in biostatistics, data management, and SCORE-related education
and training, including assistance with study design, implementation, data collection, analysis, and publication.
This has been a successful approach that we will replicate and build on in the next cycle. In the current
proposal, we will continue to focus on data collection, management, and analysis for the SCORE’s tripartite,
longitudinal Bone, Brain, and Heart (B/B/H) study and on SCORE-related education and training. In addition,
we will further strengthen the SCORE’s science by adding bioinformatics expertise to the Core, converting the
Biostatistics Resource Core into the Biostatistics and Bioinformatics Resource Core (BBRC). This will enable
us to apply valuable omics (metabolomics, metagenomics) insights to B/B/H research questions and provide
additional resources for SCORE-related education and training.

Public health relevance
PROJECT NARRATIVE – Biostatistics and Bioinformatics Resource Core (BBRC) The goal of Emory University's U54 SCORE research program is to improve the health and wellbeing of women by promoting women's health research and normalizing the inclusion of sex as a variable in all domains of biomedical research. To achieve that end, the overall objective of the BBRC is to enhance the success of Emory SCORE research through high quality collaborative support in biostatistics, bioinformatics, data management, and SCORE- related education and training. In this way, the BBRC will enhance the rigor of SCORE research, improve the merit of SCORE publications, and expand the field of collaborative biostatistics in the area of women's health and sex differences.